Dissecting myeloid cell-mediated resistance to immune checkpoint blockade in bladder cancer

Immune checkpoint inhibition (CPI) with anti-PD-1/PD-L1 antibodies has changed the treatment
landscape for several types of cancers including bladder cancer. In patients with advanced bladder cancer,
CPI can induce unprecedented durable responses. However, only a subset of patients responds to such
treatment necessitating a better understanding of mechanisms of primary resistance to facilitate the
identification of predictive biomarkers and rational combination approaches. We used an integrative approach
to identify biomarkers in a large clinical trial cohort of patients with metastatic bladder cancer that are
independently associated with response/resistance to CPI beyond tumor mutational burden (TMB) alone. We
identified three key gene modules derived from pre-treatment tumor transcriptomic data: a “good immune”
module associated with response to CPI, a stromal module associated with resistance to CPI, and a “bad
immune” module also associated with resistance to CPI, but that appears to mediate the negative impact of
the stromal module upon outcomes with CPI. Using single cell RNA sequencing data generated from fresh
bladder cancer specimens to dissect the cellular components and molecular interactions responsible for
expression of these 3 gene modules, we determined that the “good immune” module emanates largely from T-
cells and NK cells, the stromal module emanates from cancer-associated fibroblasts (CAFs), and the “bad
immune” module emanates predominantly from monocytes-macrophages (MΦ). We hypothesize that myeloid
cells drive primary resistance to CPI in bladder cancer. We further hypothesize that comprehensive cellular
and molecular maps of bladder cancer will facilitate identification of precise monocyte-MΦ subpopulations, and
CAF-myeloid-T-cell interactions, that can be leveraged to define novel biomarkers and therapeutic targets.
With access to a unique set of clinical trial cohorts that will provide tumor tissue, blood and urine
specimens as well as outcome data to CPI, we are uniquely positioned to: (Aim 1) Dissect gene modules
associated with response/resistance to CPI using high resolution maps of the cellular and molecular landscape
of muscle-invasive bladder cancer; Aim 2: Define the role of “bad immune” module genes in governing
monocyte-MΦ-mediated immune suppression; Aim 3: Refine and validate a monocyte-MΦ-related gene
signature as a biomarker of CPI resistance in clinical trial cohorts.
This proposal comprises an integrated network of multi-disciplinary collaborative investigators (GU
oncologists, urologists, immunologists and bioinformaticians) to accelerate translational research and
maximize future clinical benefits. These efforts will lead to the discovery of biomarkers, and potential
therapeutic targets, to extend the benefits of CPI beyond the 15-20% of patients with advanced bladder cancer
that respond to treatment.

Public health relevance
PROJECT NARRATIVE This project is seeking to define the cellular and molecular events associated with resistance to immune checkpoint blockade in bladder cancer. Our preliminary data defines a gene signature emanating from myeloid cells associated with resistance to immune checkpoint blockade. Here, we will generate detailed atlases of bladder cancer which will refine our understanding of the precise myeloid cells associated with resistance, dissect the mechanistic basis for such resistance, and substantiate the clinical relevance of these observations.